Regulation of Growth and Proliferation by Drosophila TOR

DESCRIPTION (provided by applicant): The long term goal of this project is to understand the cellular and molecular mechanisms by which the Target of Rapamycin (TOR) kinase controls cell growth and metabolism. Work in the current budget period has established TOR as a central regulator of growth in Drosophila, and has characterized the upstream circuitry and downstream cellular processes that regulate and mediate TOR function. 1 critical unresolved question concerns the relative degree to which each of the cellular processes regulated by TOR contributes to its effects. The objective of the proposed work is to achieve a detailed understanding of how 1 such process, autophagy, contributes to TOR-dependent functions. Autophagy is a non-selective degradative process in which portions of cytoplasm are engulfed and sequestered into membrane-bound vesicles, and transported to the lysosome for breakdown and recycling. As the major route by which long-lived proteins, organelles and bulk cytoplasm are degraded, autophagy has a catabolic effect on cell growth and metabolism, and its breakdown products are essential for survival under conditions of starvation. Many of the genes that regulate autophagy have now been identified in yeast, and homologs of these genes have recently been shown to function in autophagy in metazoans. Work in our laboratory and others have shown that TOR signaling is necessary and sufficient to suppress autophagy under normal conditions;this function of TOR is conserved from yeast to human cells. We have developed a series of novel genetic reagents to induce, block or monitor autophagy in Drosophila. Using these reagents we propose to elucidate the role and regulation of autophagy in response to TOR signaling. The proposed work has 4 aims: 1) investigation of the contributions of autophagy to TOR-dependent growth, proliferation and survival;2) analysis of potential mechanisms by which autophagy influences cell growth;3) analysis of mechanisms by which TOR regulates autophagy;4) screen for novel genes required for autophagy in response to TOR signaling. TOR signaling has broad impacts on health-related issues such as tumorigenesis, neurodegeneration, and aging. Correlative and genetic data from a number of systems suggest autophagy contributes to these effects. By helping to reveal the molecular basis of TOR,Aos effects on cell growth and metabolism, this work will advance our basic understanding of these processes.